Improving medication adherence among people with diabetes who are homeless

PROJECT SUMMARY
The long-term objective of this project is to reduce the diabetes health disparities of people with type 2
Diabetes who experience Homelessness, herein abbreviated as DH. The study will focus on diabetes
medication adherence as a modifiable behavior known to correlate with glycemic control, all-cause mortality,
all-cause hospitalization, and health care cost. The aims are to: (1) Develop the initial Diabetes Homeless
Medication Support (D-Homes) treatment manual through focus groups with DH (N=30) at various levels of
glycemic control (HgA1c<7, 7-9, >9) and interviews with their multi-disciplinary providers (N=12), (2) Test
patient perceptions of the feasibility and acceptability of study procedures and refine the D-Homes treatment
manual through test cases (n=10), and (3) Conduct a pilot randomized control trial (N=54) to compare the
effect of D-Homes (weekly phone/in-person sessions over 12 weeks) vs. enhanced standard care
(identify/reinforce care team, printed educational materials) on medication adherence, glycemic control, and
health care utilization. These aims follow a sequential exploratory mixed methods approach. Qualitative focus
groups and interviews will gather data about the values, preferences, and barriers to medication adherence
faced by DH and their response to proposed intervention components. The initial protocol will be developed
using existing evidence-based models and interventions to improve medication adherence, specifically the
Information Motivation Behavioral Skills and Collaborative Care Models and use of motivational interviewing as
a counseling style. It will also include explicit support for housing, food access, and other psychosocial needs.
We will further tailor our protocol by conducting ten test cases. A final protocol will be developed by integrating
qualitative and quantitative findings from Aims 1 and 2 with input from a multi-stakeholder panel with providers
and community members with lived experience of these issues and the mentorship team. This project will
prepare Dr. Vickery for a career as an independent investigator focused on overcoming diabetes and other
health disparities among historically disadvantaged groups. Her career development plan includes training
goals to: (i) develop tailored, theory-based behavioral interventions to address the needs of vulnerable groups
using mixed methods data, (ii) learn to conduct rigorous behavioral trials and statistical methods for analyzing
results, (iii) learn to develop and use measures of patient-centered outcomes and medication adherence, (iv)
advanced manuscript and grant-writing skills. The research will be conducted in an ideal environment,
Hennepin County Medical Center, the largest safety net health care system in the region, and its research arm,
the Minneapolis Medical Research Foundation. It will be further strengthened by Dr. Vickery’s appointment as
an Assistant Professor at University of Minnesota, a large academic health center with a Clinical Translational
Sciences Institute. The interviews and trial will be conducted at shelters in close collaboration with Hennepin
County Health Care for the Homeless clinics where Dr. Vickery works clinically.

Public health relevance
PROJECT NARRATIVE People with diabetes who are homeless die of preventable chronic diseases, including diabetes, at younger ages than their housed peers. Medication adherence is a modifiable behavior linked to improved mortality and diabetes-specific and overall health outcomes. The proposed work aims to design an intervention tailored to the needs of people with diabetes experiencing homelessness based on motivational interviewing and psychosocial support to improve adherence.